PET Sphingosine-1-Phosphate Receptor 1 (S1P1) radiotracer for inflammation response in multiple sclerosis

A. Project Summary/Abstract
The goal of this renewal R01 application is to identify an 18F-labeled radiotracer to quantitatively measure
sphingosine-1-phosphate receptor 1 (S1PR1) expression in multiple sclerosis (MS) patients. MS is associated
with a lymphocyte-mediated autoimmune response that ultimately leads to repeating cycles of demyelination
and repair. S1PR1 is extensively expressed on lymphocytes and endothelial cells and participates in this
autoimmune inflammatory process by regulating immune cell trafficking in the brain. Currently, four S1P
modulators fingolimod, siponimod, ozanimod, and ponesimod have been approved by FDA for treating MS, but
the pathophysiologic mechanism of S1PR1 in MS is still not well understood. Positron emission tomography
(PET) investigating S1PR1 function in MS and other diseases is limited by the lack of a clinically suitable
radiotracer. To address this urgent clinical need, our team successfully transferred [11C]CS1P1, a C-11 S1PR1
radiotracer into clinical investigation. Our human study data confirm that liver is the critical organ for radiation
dose absorption and that [11C]CS1P1 is safe for patient who receives a dose of up to 740 MBq (20 mCi). Our
proof of concept brain studies showed higher uptake of [11C]CS1P1 in gray matter than in white matter, consistent
with S1PR1 mRNA expression in the normal human brain. In MS patients, we observed increased [11C]CS1P1
uptake within both brain lesions and normal appearing white matter (WM). These results are consistent with
extant evidence of inflammatory infiltrate in both the brain lesions and normal appearing WM in MS. Together,
our data suggest that PET measurement of S1PR1 protein expression could provide a unique method to detect
neuroinflammation and response in MS patients. Our initial radiometabolite analysis of human plasma
discovered a lipophilic radiometabolite post injection of [11C]CS1P1 and led to initial concerns. However, we
recently confirmed the molecular structure of the radiometabolite, and radiometabolite analysis of the rat brain
and plasma post-injection of the radiotracer and PET brain studies of the F-18 labeled radiometaobolite
demonstrated the radiometabolite does not enter into the brain. Additionally, our team has synthesized ~120
new structurally diverse S1PR1 ligands, and ~30 of them are highly potent (IC50 < 20 nM) and selective for
S1PR1. To date, our preliminary data indicate that three F-18 radiotracers are promise for S1PR1 imaging, two
of them are F-18 labeled using different procedures and are anticipated to have different pathway compared to
[11C]CS1P1. Therefore, in this renewal phase, we will leverage our recent experience with [11C]CS1P1 and
develop and transfer an 18F-labeled S1PR1 tracer for clinical investigation. We propose two specific aims: 1)
Identify and transfer the most promising 18F-labeled S1PR1 tracer into human investigations. 2) Implement PET
imaging human studies in healthy controls and MS patients. When the completion of this application, a clinical
suitable S1PR1 18F-radiotracer will be identified and ready to implement for MS and other inflammatory diseases.

Public health relevance
Multiple sclerosis (MS) results from an immune-response which triggers inflammation and demyelination in the central nervous system (CNS). There are an estimated 450,000 MS patients in United States alone. Unlike many other neurodegenerative diseases, MS affects mainly young adults; the lifetime direct and indirect costs estimated at $1.2 million per patient. Several sphingosine-1-phosphate receptor 1 (S1PR1) modulators had been approved by FDA for treating relapsing-remitting MS (RRMS) and show good efficacy. The PET with a imaging agent to measuring of S1PR1 expression my provide an innovative biomarker to predict, diagnose, and monitor the progression of MS, as well as valuate the efficacy of treating RRMS and other inflammatory diseases using S1PR1 inhibition strategy.